Molecular Dysregulation in Fuchs Corneal Endothelial Dystrophy

Fuchs Endothelial Corneal Dystrophy (FECD) is a blinding disease that affects 4% over the age of 40 in
the United States. There is no cure for this condition. Corneal tranplantation is the prevalent treatment.
With the aging population, there is increasing scarcity of donor tissues. In addition, tranplant failures due
to graft rejections occur in 10-25% of corneal transplantations. This proposal focuses on identifying
previously understudied molecular signaling pathways in FECD. Successful completion of the specific
aims in this proposal can lead to alternative therapies for FECD.

Public health relevance
Fuchs corneal endothelial dystrophy (FECD) is a blinding disease that affects millions of people each year in the United States. Corneal transplantation is the common treatment for this condition. In the current proposal, I outline experiments to identify and characterize the molecular mechanisms that lead to disease progression in FECD with the objective of identifying therapeutics.